Molecular and Cellular Mechanisms in Cancer

PROJECT SUMMARY
!
The objective of this training program is to provide post-doctoral fellows with didactic and research experience
in cellular and molecular aspects of cancer to prepare them for independent investigative careers in basic and
translational cancer research. The program forms the core of cancer biology training in the Helen Diller Family
Comprehensive Cancer Center (HDCCC) at the University of California, San Francisco (UCSF). The faculty,
who are all members of the HDCCC, consists of basic researchers, laboratory-based physician-scientists, and
more applied clinician-investigators who share common interests in the multifaceted fields of cellular, molecular
and structural biology applied to the understanding of mechanisms of cancer initiation, progression, diagnosis
and therapy. The areas of didactic and research training will expose trainees to a spectrum of approaches,
concepts and opportunities from altered gene and protein structure and expression, cancer microenvironment
and immunity, cell cycling and signaling to differentiation and development. The goal of this approach is to
further the understanding of cancer incidence and progression so that the trainees will have an appropriate
perspective to approaching basic cancer research as well as to address, prevention, biomarkers and
translation to patients. Post-doctoral trainees will join one of 37 research groups involved in studying these
basic mechanisms. To broaden their experience, the trainees will have secondary mentors and will be
encouraged to seek out collaborations with other research groups at UCSF or outside. Because of the
significance and need for training in Bioinformatics and Computational Biology for modern cancer research, we
have initiated a workshop for our trainees, taught by the Program faculty. Trainees will have access to all the
academic resources available at UCSF. In this way, trainees will be provided with an in-depth research
experience in an environment that covers the broad forefront of molecular and cellular dysregulation in cancer.
Seminar programs, research-in-progress discussions and journal clubs complement the research training.
Trainees must have a Ph.D. or equivalent degree in cell or molecular biology, genetics, biochemistry or an
applicable discipline, or an M.D. or M.D., Ph.D. The trainees will be selected on the basis of past
accomplishments and promise, course work, grades achieved, suitability for the research projects and a
commitment to a research career. Trainees will receive a stipend for an average of 2 years, but will be part of
the program throughout their training period of at least 3 years. The program will consist of 8 trainees,
complemented by the larger group of other trainees in the host laboratories to make a significant critical mass
of basic cancer researchers in the CCC. Upon completion of the program, it is anticipated that the trainees will
continue careers in basic and translational cancer research in academic institutions, governmental agencies or
the biotechnology industry.

Public health relevance
PROJECT NARRATIVE The goal of this application is to continue a highly successful training program that has produced diverse and broadly trained scientists over the last 15 years. This highly trained workforce of basic scientists and physician/scientists will be at the forefront of cancer research in the coming decades and will assume leadership roles to produce the scientific data to improve diagnosis, survival rates and quality of life of individuals with cancer.